Membrane properties of the OHC system

Project Summary
In this proposal we hope to build on our efforts defining the cryoEM structure of prestin, the OHC lateral wall
motor responsible for cochlear amplification, in the depolarized and contracted state. In this proposal we seek to
define the protein's structure in the expanded state brought about by voltage. We will use complementary
methods to determine its structure exploiting recent advances in image processing and using temperature and
mutations that affect its violtage sensitivity. In addition, we will also be using modeling using molecular dynamics
simulations to understand its structure under voltage control.

Public health relevance
Project Narrative We are trying to understand how a single molecule, prestin, can influence the mammal's exquisite sense of hearing by studying its cryo-EM structure. We propose to study the influence of voltage and other manipulations that alter its voltage-dependent state to identify conformations that normally occur duing outer hair cell activity. This will aid in understanding how the OHC enables us to hear so well and in turn how we might combat pathologies of the OHC that afflict millions.